Harnessing the RNA-Binding Properties of Cas13a for HIV-1 Self-Testing

PROJECT ABSTRACT
Current HIV-1 RNA detection relies on reverse transcription before PCR-based amplification, which introduces
unwanted variables and cannot be easily performed outside a laboratory. The central hypothesis of this
application is that the RNA-binding properties of newly discovered CRISPR/Cas13a proteins are suitable for
sensitive at-home detection of HIV-1 RNAs without employing RT or amplification steps. This hypothesis was
formulated on the basis of the recent discovery by the Doudna Lab that Cas13a binds and cleaves target
single-stranded RNAs in a sequence-specific manner (cis cleavage) and subsequently exerts general RNase
activity (trans cleavage) that can be exploited for fluorescence-based measurement of the target RNA. In
unpublished preliminary results, the Ott/Doudna Labs also show that recombinant Cas13a in combination with
HIV-1-specific guide RNAs (crRNAs) enables sensitive detection of HIV-1 RNAs. The central hypothesis will be
tested in a two-pronged, highly milestone-driven approach: in the innovation phase (R61), two aims will define
the optimal Cas13a homologue/crRNA combination for reliable HIV-1 detection and optimize the read-out
technology for home use. Aim 1: To optimize guide RNA (crRNA) and Cas13a protein selection. The applicants
will design HIV-specific crRNAs recognizing conserved accessible regions of the target HIV-1 genome and
systematically test Cas13a homologs from different bacteria for HIV-specific cis and trans cleavage. At the end
of the R61 period in order to progress to the R33 phase, the team will have identified ≥3 optimized crRNA
spacer sequences in the HIV-1 genome, selected ≥1 Cas13a homologs with high HIV-specific cis- and trans-
ssRNA cleavage rates with low background. Aim 2: To enhance read-out technology and optimize for self-
testing. In preliminary results, the Fletcher Lab measured E. coli DNA after PCR amplification detecting
fluorescence from an intercalating dye with iPhone-based technology. The applicants will define the optimal
sequence for trans-cleavage by Cas13a versus human RNase proteins as well as optimize fluorophore and
quencher moieties on the detection oligonucleotide for measurements with mobile phone-based reverse lens
microscopy (CellScope). At the end of the R61 period in order to progress to the R33 phase, ≥1 detection
sequence will have been identified and ≥1 fluorescence/quencher combination will have been optimized for
CellScope detection. The R33 phase consists of one aim, rigorously comparing Cas13a-CellScope results with
conventional viral load assays in acutely and chronically infected individuals and adapting the method to home
use. Aim 3: To apply optimized Cas13a assay parameters towards building a self-testing device using clinical
samples. The team will optimize HIV-1 RNA detection in the context of plasma, serum and whole blood,
enhance stability of the test system at room temperature and analyze cryopreserved and fresh patient samples
provided by Dr. Deeks from the SCOPE cohort. It is anticipated that the work completed during this grant will
develop fundamentally new technology to enable early and frequent monitoring of HIV-1 infection at home.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health; it will develop a fundamentally new test for HIV RNA detection suitable for home use. Such a device would have substantial benefit to the field because it would advance early detection of acute infections and monitoring of chronic infections during treatment interruptions. The project is relevant to NIH's mission as it fulfills one of the high-priority topics of research for support using AIDS-designated funds, reducing the incidence of HIV/AIDS.